Center for Appalachian Research in Environmental Sciences

The University of Kentucky Center for Appalachian Research in Environmental Sciences (UKCARES) will build on our early successes, capitalize on lessons learned, and enhance our mission through a dual focus on better understanding exposure pathways and emerging environmental health threats and optimizing research translation. Our Mission is to focus on exposure pathways to better match with community concerns and to emphasize research translation. Our Values reflect strong, multidirectional community-academic partnerships, with a renewed commitment to meaningful processes and procedures that effectively address environmental health issues. Responsible conduct of research is at the foundation of our Center, appreciating the essential value of rigorous and reproducible multidisciplinary team science. Our goals are to (a) advance multidisciplinary environmental health science (EHS); (b) analyze organic contaminants and trace elements; (c) cultivate early-stage stage and established investigators; (d) learn with and from the community, helping to inform and translate our research; and (e) build science communication skills with investigators and community partners to boost research translation. We will advance EHS across the translational spectrum around three highly integrated science themes informed by residents of rural Appalachia: 1) Health Impacts of Waterborne Contaminants (WATER); 2) Health Impacts of Indoor and Outdoor Airborne Contaminants (AIR); and 3) Emerging Environmental Health Threats (EMERGING THREATS). The central hypothesis is that exposure to established contaminants via environmental exposure pathways (e.g., water, air) and emerging environmental health threats, combined with lifestyle and societal risk factors, contributes to the disproportionately high incidence of chronic diseases in rural Appalachia. UK-CARES draws on a strong base of EHS and community-engaged research to meet the needs of communities in rural Appalachia. We will support and mentor investigators so they can reach the translational milestones in research: (1) asking fundamental questions; (2) applying and synthesizing; (3) implementing and adjusting; (4) moving ideas to practice; and (5) creating impact. In short, UKCARES will leverage its resources to enhance EHS at UK while also reducing the impact of chronic diseases in rural Appalachia. A Translational Research Support Core, Analytical Chemistry Core for Environmental Sciences, and Community Engagement Core are integral to this effort, as these cores will provide dedicated support in analytical chemistry, trace-elements analysis, biospecimen management, and bioinformatics and bridge Center and community priorities. The Pilot Project Program supports developing research and new scientific directions, advancing the careers of scientists interested in tackling challenging environmental health questions. UK-CARES will positively impact rural Appalachia through collaborative EHS designed to generate and disseminate new knowledge and translate research to inform clinical decision making.

Public health relevance
The University of Kentucky Center for Appalachian Research in Environmental Sciences (UKCARES) will enhance programmatic and scientific capacity to facilitate innovative discovery and new understandings of environmental exposure pathways of concern to our community (e.g., water, air, emerging threats). Further, the Center will foster career development of environmental health scientists interested in tackling challenging environmental health questions facing rural Appalachia. UK-CARES will achieve these goals by providing advanced infrastructure and expertise, cross-disciplinary training and mentorship, and multidirectional community-academic partnerships to reduce chronic disease health risks in rural Appalachia.